Advanced Training in Oral Biology

PROJECT SUMMARY/ABSTRACT
This competing-continuation T32 application (Advanced Training in Oral Biology) requests funding to support
the research career development of eligible applicants who wish to pursue careers as independent
investigators and leaders in dental, oral, and craniofacial health research. Trainees of our long-established
program are encouraged to follow their interests to become prepared to lead a research program involving
basic, translational and/or clinical research, participate as expert investigators in multidisciplinary team science
projects, and provide leadership in biomedical science research. The major research areas encompassed by
the program include microbiology, salivary research, genomics-glycomics-microbiome studies, craniofacial and
tooth development, hard-tissue biology, host defense, and periodontal research. The proposed duration of the
training leading to completion of the PhD degree is 4 years. For post-doctoral training, 3 years are proposed.
The Ph.D. and post-doctoral training programs in the Department of Oral Biology at the University at Buffalo
(UB) School of Dental Medicine have to date supported 90 individuals who have earned their Ph.D. degree in
Oral Biology, and a large number of post-doctoral fellows, most of whom entered the faculties of numerous
dental schools, research institutes, and industry research programs throughout the world. The Training Faculty
includes a diverse mix of 23 investigators who lead productive research programs with substantial experience
in training pre-doctoral and postdoctoral fellows. Trainees will benefit from many available resources and
learning opportunities, including a strong didactic curriculum, journal clubs and seminars, access to basic
science and clinical research core facilities, and career development activities. After successfully completing
their training, we anticipate our trainees to have reached a level of experience in experimental techniques,
scientific thinking, and academic skills that will enable them to pursue successful careers as independent
scientists in research, industry, and clinic.

Public health relevance
PROJECT NARRATIVE The Advanced Training in Oral Biology program at the School of Dental Medicine at the University at Buffalo offers a wide range of research-intensive interdisciplinary graduate and post-doctoral programs to train the next generation of oral health biomedical scientists. The goal of the program is to attract pre-doctoral and post- doctoral trainees into oral biology research careers. This proposal requests continuation of support for both our Ph.D. program to train dentists (post-D.D.S.) and non-dentists (pre-doctoral), and for our post-doctoral program to train post-doctoral fellows.